Autonomous Navigating Robot for Detecting Falls and Risk of Falls in Nursing Home Residents with Alzheimer's Disease /ADRD

ABSTRACT
Between half and three-quarters of nursing home (NH) residents fall each year. About 5% of
adults 65 and older live in nursing homes, but nursing home residents account for 20% of
deaths from falls in this age group. 50% of nursing home residents have moderate or severe
cognitive impairment. Older adults with Alzheimer’s Disease or ADRD are more likely to fall than
their peers without cognitive impairment. Falls often have serious consequences, especially in
frail older residents. One in every 10 residents who fall has a serious related injury and about
65,000 patients suffer hip fracture each year. Residents who fall without injury often develop a
fear of falling that leads to self-imposed limitation of activity leading to a decrease in the ability
to function and a reduced quality of life. Falls have major consequences for facilities including
increased levels of care required for fallers, increased paperwork for staff, poor survey results,
lawsuits and higher insurance premiums. Most falls (66%-75%) occur in the resident’s room and
almost half (48%) end in an injury. Treating a person shortly after falling is critical to the
recovery from the fall both physically and mentally. Existing fall detection systems use static
cameras in the rooms of residents which violate resident privacy and may be unable to detect
falls that are hidden from the camera or that occur in the dark. The acute shortage of staff in
nursing homes may create situations where a fall is undetected for a while.
The proposed study involves integration of an affordable autonomous navigating robot which
has been used successfully in nursing home dementia units, with an infra-red camera, image
processing software and AI to be an additional “set of eyes” to patrol the corridors and rooms of
nursing homes residents and to detect falls and risk of falls and alert staff so they can be
handled immediately.

Public health relevance
NARRATIVE Between half and three-quarters of nursing home (NH) residents fall each year. 50% of nursing home residents have moderate or severe cognitive impairment. Older adults with Alzheimer’s Disease or ADRD are more likely to fall than their peers without cognitive impairment. Falls often have serious consequences, especially in frail older residents. Falls have major consequences for facilities including increased levels of care required for fallers, increased paperwork for staff, poor survey results, lawsuits and higher insurance premiums. Treating a person shortly after falling is critical to the recovery from the fall both physically and mentally. Existing fall detection systems use static cameras in the rooms of residents which violate resident privacy and may be unable to detect falls that are hidden from the camera or that occur in the dark. The acute shortage of staff in nursing homes may create situations where a fall is undetected for a while. The proposed study involves integration of an affordable autonomous navigating robot which has been used successfully in nursing home dementia units, with an infra-red camera, image processing software and artificial intelligence to be an additional “set of eyes” to patrol the corridors and rooms of nursing homes residents and to detect falls and risk of falls and alert staff so they can be handled immediately.